Malaria vaccine evaluation in a novel infant NHP challenge model

PROJECT SUMMARY
The objective of this proposal is to develop a novel infant rhesus malaria challenge model and use this model to
determine how age impacts immune responses to malaria vaccination and protection at challenge. Malaria,
caused by Plasmodium parasites, is responsible for 225 million infections and 400,000 deaths per year. Malaria
burden is unevenly distributed by age, with infants and children suffering most. There is currently no licensed
malaria vaccine that can provide high level efficacy and reduce transmission in these populations. The most
advanced vaccine candidates target the malaria sporozoite and liver stages, which precede the symptomatic
blood stage of infection. These include the subunit vaccines RTS,S, R21, and ME-TRAP, and the live-attenuated
sporozoite vaccine PfSPZ. These vaccines confer protection by inducing anti-sporozoite antibodies or cytotoxic
T cells that kill infected cells in the liver. While these candidates have shown promising vaccine efficacy in adults,
age de-escalation trials have revealed vaccine immunogenicity and efficacy vary with age, with a trend for poorer
vaccine efficacy in younger infants. This has been attributed to the inherently tolerogenic nature of the infant
immune system, which gradually changes as the individual ages and becomes more immunologically mature.
Non-human primates (NHPs) are excellent models of the human immune system and pre-clinical studies in adult
rhesus macaques have directly informed malaria vaccine clinical trials. For vaccines that induce liver-specific T
cell responses, NHPs have been particularly valuable for identifying tissue correlates of protection since the liver
is typically inaccessible in vaccine clinical trials. Yet, despite infants and children being the target population for
malaria vaccines, there is currently no infant NHP challenge model for malaria vaccine evaluation. This proposal
will address this critical gap by establishing a novel infant rhesus malaria challenge model and using it to define
the effect of age on immune responses to malaria vaccination and protection at challenge. This model will use
the NHP-adapted Plasmodium knowlesi (Pk) malaria parasite and the well-characterized PkSPZ live-attenuated
sporozoite vaccine, which is equivalent to the PfSPZ vaccine recently tested in human infants. This vaccine
strategy is ideal as it is known to induce antibodies and T cell responses in both the periphery and liver and
confer substantial protection in adult rhesus macaques. The study design will age de-escalate and enroll one
cohort young adult animals and another of 5-12 month old infants. The hypothesis is that age-dependent
differences in peripheral and liver-specific immune responses to vaccination will result in decreased vaccine
efficacy in the infants. As it is infeasible to study vaccine-induced T cell responses in the liver of human infants,
this study will be the first to assess how the inherent characteristics of the developing infant immune system
impact liver T cell responses in a translationally relevant model. These studies aim to launch this novel infant
NHP research model and accelerate the development of a highly effective malaria vaccine for human infants.

Public health relevance
PROJECT NARRATIVE Non-human primates are excellent models of the human immune system, and previous pre-clinical studies in adult rhesus macaques have directly informed the choice of vaccine route, schedule and/or adjuvant for clinical assessment of malaria vaccine candidates. However, despite infants and children being the target population for malaria vaccines, no infant non-human primate malaria challenge model currently exists for vaccine evaluation. This project will develop a novel infant rhesus malaria challenge model and use this model to define how age at immunization and features of the developing infant immune system shape the response to malaria vaccination.